Administrative Core

Core A: Administrative Core
Project Summary/Abstract
The Administrative Core supports the overall mission of the Center by freeing CDE affiliates to focus their
efforts on the scientific aspects of their research and by supporting development, training, and dissemination
activities. The Core's professional and specialized staff provides faculty affiliates with a full range of services to
support grants submission and management and provides administrative support to the Development Core
and the Scientific and Technical Core. The Core plays an important role in all other Center activities including
the development and implementation of long-term priorities and new initiatives, the effective and timely
dissemination of important research findings, the coordination of training activities, and regular
communication with affiliated centers to identify collaborative research opportunities and avenues for cost-
sharing and efficiencies.